Developmental Funds

DEVELOPMENTAL FUNDS: PROJECT SUMMARY
The Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) utilizes the Cancer Center Support Grant
(CCSG) developmental funds to invest in specific efforts that support the research goals of its overall Strategic
Plan. During the current project period, a total of $903,200 of CCSG developmental funds was distributed for
pilot funding in support of 27 research projects, and to date these investments have already yielded a $16.6M
(18-fold) return on investment. More importantly, the WFBCCC leadership leveraged the CCSG developmental
funds with other Center resources during the project period, and in total it invested $3.4M in pilot awards during
the project period (minus the awards made in late 2020). This investment can be directly linked to the successful
award of $37.9M in extramural, multi-year grant funding – more than an 11-fold yield from the combined
investment. In the next project period, the WFBCCC is requesting developmental funds to support pilot projects,
and up to 20% effort for two early-stage clinical investigators annually who will be charged with developing and
launching an innovative investigator-initiated trial and maximizing WFBCCC’s participation in the National
Cancer Institute’s National Clinical Trials Network.